Precision TMS with integrated visualization and analysis of real-time E-field and EEG source imaging

Summary
Transcranial magnetic stimulation (TMS) is an FDA-approved treatment for several brain diseases, such as
major depressive disorder, obsessive-compulsive disorder, migraine with aura, and smoking cessation. However,
the response rate varies significantly across subjects related to several suboptimal treatment parameters such
as stimulation intensity and brain target for individual patients. To overcome the limitations, we will develop novel
software and computational techniques that integrate real-time navigated electric-field mapping and source-
space electroencephalogram (EEG) analysis during TMS to significantly improve the accuracy of targeting and
dosimetry for individualized subjects to enhance treatment efficacy. We propose a novel subject-specific target
localization method that integrates diffusion MRI tractography and resting-state functional brain networks to
select target regions in the dorsolateral prefrontal cortex (DLPFC) and the inferior parietal lobule (IPL) of the
frontoparietal network. We will use the electric field and source space EEG mapping techniques to guide the
stimulation of the target regions and examine related changes in cognitive control functions. We will complete
the proposed work with three aims. In Aim 1, we will further develop the SlicerTMS software from our previous
work to provide real-time E-field mapping and quantitative measures during TMS treatment. In Aim 2, we will
incorporate real-time source-space TMS-EEG measures in SlicerTMS2.0 to provide real-time feedback for target
engagement and brain activity. In Aim 3, we will validate SlicerTMS2.0 online measures by comparing them with
standard offline analysis methods with TMS-EEG experiments using the proposed DLPFC and IPL targets. We
will also examine TMS-related changes in the choice reaction time in modified multi-source interference tasks.
The outcomes of this grant will provide new tools to improve TMS stimulation targeting and dosimetry, which can
significantly enhance TMS treatment response for brain diseases.

Public health relevance
Narrative Transcranial magnetic stimulation is a noninvasive neuromodulation technique and FDA-approved treatment for several brain diseases but with significant variability in treatment response across subjects. This grant will develop novel computation techniques that use real-time electric field modeling and brain activity monitoring to improve the accuracy of stimulation targeting and dosage. Once validated, the outcomes of this grant can significantly improve the treatment efficacy of transcranial magnetic stimulation treatment.